Stem Cell and Transplantation Biology

PROJECT SUMMARY/ABSTRACT - Overall
The theme of this CCEH is focused on stem cell and transplantation biology. The aims are designed to
overcome obstacles that prevent new investigators from joining this field. Specifically the four cores will
provide investigators access to: Large numbers of human and canine stem/progenitor cells; Scalable viral
production services for AAV, gamma-, lenti- and foamy viruses; Products for precision gene editing and
functional genetic manipulation; PCR assays for tracking chimerism, and insertion sites; Xenografting to
assess human hematopoiesis; Large animal model for preclinical in vivo testing and disease modeling.
The major goal of this CCEH is to make these services available throughout the US. For this purpose,
products and services must be cost- effective and of high quality. Also training in best practices for the use
of these resources is imperative. Towards this goal core staff provide on-site training: funds to support travel
to attend training sessions are available. In addition, standard operating procedures (SOP) and quality
control measures (QC) for all processes and products are shared on our website where they can be
discussed and amended as the science evolves.
The logistics of distributing products throughout the country are challenging. However, since the first
iteration of this grant (P30 DK056465) in 1999 we have successfully shipped highly purified CD34 cells in
liquid nitrogen to hundreds of satisfied investigators. Our costs are generally less than 1/3 of the cheapest
commercial vender, and our product is better. Logistics for shipping other biological products to out of state
users are already in place.
The fees for service charged by this CCEH generates program income of $1-2 million per year. These funds
are used to increase staff, develop new technologies and to fund the Enrichment Program. The goal is to
help build a strong, diverse, interactive hematology research community. Included in this effort is a research
internship program for students from underrepresented or underserved populations.
The Seattle CCEH research base consists of 25 faculty members at the University of Washington and/or the
Fred Hutchinson Cancer Research Center. Currently our research base brings in $17,130,946 in direct costs
per year for studies in non-malignant hematopoiesis.

Public health relevance
PROJECT NARRATIVE - Overall Our goal is to attract trainees and young investigators from across the US to study normal hematopoiesis and non-malignant blood diseases that can be cured with stem cell transplantation. A diverse work force is needed to bring people with different perspectives together in synergistic collaborations which can speed discovery, however, the tools needed to advance this science may be out of reach for many independent investigators. This NIDDK Core Center addresses this challenge by providing access to resources at reduced rates, funds for pilot studies, and a virtual community of supportive colleagues.